Modulation of the Innate Immune System by Fisetin for the Treatment of AD

DESCRIPTION (provided by applicant): An increasing variety of diseases are being shown to be due to immunological processes, including diabetes, and now Alzheimer's disease (AD). AD is the most prevalent age-associated disease and growing evidence suggests that aspects of the innate immune system play a major role its progression. Based on this evidence, we propose a new approach to the treatment of AD by targeting key properties of the innate immune system involved in the progression of the disease. Microglia (or brain macrophages) are the resident immune cells of the brain. Not only are they implicated in the pathogenesis of a variety of neurological disorders including AD but they also play important, protective roles in the CNS. Thus, modulating the response of microglia following activation to favor their neuroprotective over their neurotoxic properties may be the key to harnessing the immune system to treat AD. Our studies have led to the identification of a molecule that controls microglial properties in ways that are beneficial for modulating AD progression. This is the flavonoid fisetin which our in vitro and animal studies have demonstrated inhibits TNF production in activated macrophages and microglia. Fisetin promotes the adoption of the M2 anti-inflammatory phenotype by microglia as manifested by an increase in the expression of CD45, a cell surface protein tyrosine phosphatase expressed exclusively by cells of hematopoietic lineages and by inhibition of iNOS induction. CD45 has been implicated in the inhibition of classical M1 microglial activation while driving the anti-inflammatory M2 microglial phenotype. Fisetin, a rare natural flavonoid, was initially identified in the Maher laboratory as a orally active, novel neuroprotective and cognition-enhancing molecule. Fisetin protects nerve cells from multiple toxic insults and is therapeutically active in rigorous rodent models for memory, rabbit and mouse models for ischemic stroke, mouse and fly models of Huntington's disease and in transgenic AD mice. A series of much more potent fisetin derivatives, many of which maintain in vitro anti-inflammatory activity, has recently been synthesized by SAR-driven iterative chemistry. From the 150 derivatives synthesized, we selected the best seven derivatives that maintain the biological activities of fisetin, including its anti-inflammatory actvity. Preliminary assays to assess their pharmacological properties indicate that these derivatives have the potential to be good CNS drugs. In addition, the derivatives do not suffer from the intellectual property challenges of the natural product fisetin and are covered under several issued and/or pending patents held by the Salk Institute. We propose to advance fisetin derivatives as modulators of innate immune function and clinical candidates for the treatment of AD. Specifically, we plan to (1) further characterize the induction of the M2 microglial phenotype by fisetin and fisetin derivatives in vitro; (2) identify which of the pre-selected fisetin derivatves induce the M2 phenotype in vivo and then determine which have pharmacokinetic properties most consistent with good CNS drugs and (3) test the best two fisetin derivatives in AD transgenic mice for effects on behavior and pathology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Currently there are no drugs that can prevent, slow or stop the progression of Alzheimer's disease. We propose to develop a novel group of compounds based on a small molecule natural product to harness the good aspects of the brain's immune system in order to prevent the loss of brain function in Alzheimer's disease. If successful, this approach could prove beneficial for the treatment not only of Alzheimer's disease but also a number of other age-related neurological disorders. __SpecificAimsTextDelimiter__ Specific Aims An increasing variety of diseases that impair various parts of the body are being shown to be due to immunological processes, including diabetes, rheumatoid arthritis and now neurodegenerative diseases such as Alzheimer's disease (AD). AD is the most prevalent age-associated disease where there are no treatments that can prevent, delay, slow or stop its progression. A number of clinical studies have demonstrated disturbances of both the systemic and CNS immune systems in AD. However, clinical trials aimed at modulating the immune system in AD patients have had disappointing results. One key reason for this is likely the dual nature of the resident immune cells of the brain, microglia (or brain macrophages). Not only are they implicated in the pathogenesis of a variety of acute and chronic neurological disorders including AD, but they also play important, protective roles in the CNS. Thus, modulating the response of microglia following activation to favor their neuroprotective over their neurotoxic properties may be key to harnessing the immune system to treat AD. One protein associated with the neuroprotective, anti-inflammatory M2 phenotype of microglia is CD45, a cell surface protein tyrosine phosphatase expressed exclusively by cells of hematopoietic lineages. Recent studies showed that CD45 can modulate the development and progression of AD in mice supporting the hypothesis that enhancing the M2 phenotype while inhibiting the classical M1 phenotype could provide a new approach to the treatment of AD. Fisetin, a rare natural flavonoid, was initially identified in the Maher laboratory as an orally active, novel neuroprotective and cognition-enhancing molecule. Fisetin protects nerve cells from multiple toxic insults including oxidative stress, ischemia and hyperglycemia. It has both direct antioxidant activity and it can increase the intracellular levels of the major endogenous antioxidant, glutathione. Fisetin is therapeutically active in rigorous rodent models for memory, rabbit and mouse models for ischemic stroke, mouse and fly models of Huntington's disease, diabetic kidney and CNS complications and in transgenic AD mice (see Background). Importantly, fisetin blocks the activation of both NF- B and JNK in microglia and peripheral macrophages in vitro and reduces TNF production and inflammation in the brain in vivo following an ischemic insult. However, it is not a general immunosuppressant. In addition, fisetin increases CD45 expression in microglia both in vitro and in vivo. Thus, fisetin can be used to specifically modulate the CNS immune response to treat AD. A series of much more potent fisetin derivatives, many of which maintain in vitro anti-inflammatory activity, has recently been synthesized by SAR-driven iterative chemistry. From the 150 derivatives synthesized, we selected the best seven derivatives in terms of potency and medicinal chemical properties that maintain the biological activities of fisetin including anti-inflammatory activity. Preliminary assays to assess their pharmacological profile indicate that these derivatives have the potential to be good CNS drugs. In addition, the derivatives do not suffer from the intellectual property challenges of the natural product fisetin and are covered under several issued and/or pending patents held by the Salk Institute. The goal of this proposal is to further develop these derivatives for the treatment of AD based on their ability to modulate microglial function. In order to do this, we propose the following three specific aims: Aim 1: We have identified a small molecule, the flavonoid fisetin, that can up-regulate CD45 levels on microglia in vivo and in vitro (see Background). CD45 is associated with the M2 neuroprotective phenotype of microglia. However, other markers are also associated with the M2 phenotype. Whether fisetin can also modulate these markers is not yet known but is important for the full characterization of both fisetin and fisetin derivatives in vivo. In addition, we will gain additional insight into how the fisetin-dependent up-regulation of CD45 in primary microglial cells in culture contributes to the induction of the M2 phenotype. Aim 2: We will identify which of the pre-selected fisetin derivatives induce the M2 anti-inflammatory phenotype in vivo and also determine which have pharmacokinetic properties most consistent with good CNS drugs. Aim 3: We will test the best two fisetin derivatives in AD transgenic mice for effects on behavior and pathology.